GROWTH HORMONE ON LIVER PROTEIN SYNTHESIS IN PATS AFTER LIVER TRANSPLANTATION

To possibly improve protein balance, we studied the effects of growth hormone (GH) on whole body protein metabolism and on synthesis of hepatic export proteins albumin and VLDL apolipoprotein B in 10 patients after liver transplantation. Five patients received only standard postoperative treatment (controls), 5 patients were given additionally GH (2x8 I.U. per day for 14 days). Calorimetry and 4h-tracer leucine infusions were performed 5 days after surgery. Tracer incorporation was measured for albumin by IRMS (N=6), for apoB by GCMS (N=10). The clinical course was similar for both groups. Cumulative urea nitrogen excretion (days 1-4, X D(SD) tended to be lower after GH: CO 60. Differences in leucine oxidation , protein breakdown 145 and non-oxidative leucine disposal were not statistically significant. Plasma albumin levels , fractional synthetic rates (0.22(0.13 vs 0.15(0.07 pools/day) and albumin production were similar. In conclusion, after major surgery, GH tends to lower nitrogen excretion and increase total body protein turnover without affecting hepatic export protein synthesis.